Novel Effectors of FGF Signaling in Craniofacial Development

Project Summary
The Fibroblast Growth Factor (FGF) signaling pathway consists of eighteen FGF ligands and four
FGF receptors (FGFRs), members of the receptor tyrosine kinase (RTK) family. FGF signaling is integral to
mammalian development and is active throughout numerous tissues and stages in the developing embryo.
Additionally, FGF signaling is a major coordinator of craniofacial morphogenesis. Misregulation of FGF is
implicated in a wide range of congenital disorders, such as cleft lip or palate (CL/P). Numerous studies have
examined the role of individual ligand-receptor combinations necessary for different aspects of development,
as well as the various intracellular signaling pathways that are activated downstream of FGF signaling.
FGFRs have been shown to recruit various adaptor proteins that facilitate the propagation of intracellular
signals such as the ERK1/2 and PI3K pathways. Previous work by the Soriano lab has shown that FGF
controls craniofacial development through the combinatorial recruitment of various effectors that activate
multiple downstream signaling pathways. However, there are still gaps in the complete picture of how FGF
signaling is relayed downstream of receptor activation, as abrogating the binding of known effectors does not
replicate the phenotype of Fgfr null mutations. The aim of this proposal is to identify these missing effectors.
I will utilize two complementary approaches to identify novel effectors of FGF signaling: a hypothesis-driven
candidate approach and an unbiased protein screen through stable isotope labeling by amino acids in cell
culture (SILAC) coupled with mass spectrometry (MS). To analyze the potential roles of these effectors, I will
utilize in vivo and in vitro techniques to assay genetic interactions and cellular functions. I will quantify
cellular proliferation, death, and migration, and changes in downstream signaling dynamics, both in the
presence of wild-type or signaling mutant backgrounds. From those targets that exhibit positive evidence of
downstream interaction with FGFRs, we will select critical genes for further biochemical and genetic
analysis. Utilizing a neural crest specific Cre line, Wnt1Cre2, we will examine the role of each novel effector
in craniofacial development on their own, or in conjunction with Fgfr null or signaling mutant backgrounds to
verify in vivo genetic interaction. The innovative studies proposed here aim to provide novel insight into the
mechanism by which FGFR activation propagates intracellular signals to coordinate the complexity of
craniofacial development. Our research strategy will utilize an array of existing reagents, alongside newly
developed strains, to uncover missing aspects of FGF signaling and provide new avenues for therapeutic
intervention and prevention of congenital craniofacial disorders.

Public health relevance
Project Narrative Fibroblast Growth Factor (FGF) signaling is a cellular signaling pathway that coordinates a multitude of developmental processes, with disruption to FGF activity associated with numerous diseases and syndromes including craniofacial congenital defects. Cleft lip and/or palate is one of the most common birth defects in humans worldwide, occurring at a rate of about 1 in 1000 births. The studies in this proposal aim to identify the mechanisms by which FGF signaling engages multiple intracellular signaling pathways to provide a deeper understanding of craniofacial development and new avenues for therapeutic approaches.